Minor Cannabinoids and Terpenes: Preclinical Evaluation as Analgesics

PROJECT SUMMARY
Throughout recorded history, humans have used natural products for medicinal purposes. With the onset of
modern analytical and pharmaceutical methods, the active ingredients in some of these “natural remedies” were
identified and became foundational chemicals in drug development efforts. Among the numerous examples,
aspirin (bark of the willow tree), capsaicin (chili peppers), and opioids (opium poppy plant) are notable for their
analgesic properties. Similar to these other natural products, Cannabis sativa has long been used for medicinal
purposes, including pain relief. The cannabis plant (Cannabis sativa/indica) contains over 100
phytocannabinoids as well as over 500 other identified chemicals, including the terpenoids that give cannabis its
distinctive flavoring and aroma. Beyond 9-THC and CBD, however, difficulties in identifying, isolating and
purifying minor phytocannabinoids in quantities sufficient for in vivo evaluation have hampered adequate
investigation of potential therapeutic uses of individual phytocannabinoids. Recently, we have secured access
to purified minor cannabinoids synthesized via a patented biosynthetic process in quantities that allow for
preclinical in vivo testing. The goal of the proposed project is to provide a comprehensive evaluation of these
compounds alone, and in planned combinations, to determine their potential efficacy as analgesics. In addition,
we will conduct a parallel investigation of selected terpenes that have been identified in the cannabis plant. Novel
analgesic strategies are needed to combat over-reliance on opioids and the resulting secondary consequences
of dependence and morbidity/mortality.

Public health relevance
PROJECT NARRATIVE Throughout recorded history, humans have used natural products, including the cannabis plant (Cannabis sativa/indica), for medicinal purposes. However, like other natural products, cannabis is not a single chemical entity, but rather contains over 100 phytocannabinoids as well as over 500 other identified chemicals, including the terpenoids that give cannabis its distinctive flavoring and aroma. Recently, we have secured access to purified minor cannabinoids synthesized via a patented biosynthetic process in quantities that allow for preclinical in vivo testing. The goal of the proposed project is to provide a comprehensive evaluation of these compounds alone, and in planned combinations, to determine their potential efficacy as analgesics. In addition, we will conduct a parallel investigation of selected terpenes that have been identified in the cannabis plant. Discovery of non-opioid analgesics could have a major impact on reducing opioid-associated morbidity and mortality.